5th Annual MAC (Midwest Aging Consortium) Aging Research Symposium

Abstract
This application requests partial funding for the 2024 Symposium of the Midwest Aging Consortium (MAC). The
conference will be held April 28-30, 2024, at the Blackwell Hotel on the Ohio State University campus in
Columbus, OH.
The expected attendance is 150-200, including basic scientists, physician-scientists, clinicians, and other
health professionals. Speakers and attendees will integrate junior and senior investigators and trainees
specializing in various scientific disciplines (cell biology, cancer, genetics, medicine, and geriatrics). This
conference represents the 5th annual MAC meeting with a unique blend of cutting-edge science in the field of
aging. The specific topics to be covered at this conference include:
(1) Cellular Senescence and Aging;
(2) Cancer and Aging;
(3) Metabolism and Aging;
(4) Exercise and Aging;
(5) Biomarkers of Aging;
(6) Stress Response and Aging.
We believe that this meeting is unique, timely, and significant because it will bring together recognized experts
from more than ten institutions in the Midwest, including the Mayo Clinic, University of Wisconsin, Minnesota,
Michigan, Iowa, Indiana, Northwestern, North Dakota, Ohio State, and Illinois-Chicago, which are all leading
institutions in aging, cell biology, genetics, and geriatrics. This 5th MAC symposium is designed to disseminate
new information and promote the interaction between established and junior investigators. This meeting will
provide a framework for novel approaches and future age-related disease research directions.

Public health relevance
NARRATIVE This application requests partial funding for the 2024 5th Symposium of the Midwest Aging Consortium (MAC). The conference will be held on April 28-30, 2024, at the Blackwell Hotel on the Ohio State University campus in Columbus, OH. According to the census in 2020, 55.8 million or 16.8% of the population of the United States in 2020. This MAC symposium brings together top scientists from multiple disciplines and institutions to advance this vital field while striving for an inclusive meeting that actively involves junior scientists.